Improvement of small molecule ClpP activators for use in hybrid antibiotics

Project Summary
Antibiotic-resistant pathogens are an ongoing clinical crisis as multi-drug resistance increases the rate of
treatment failure. Staphylococcus aureus (S. aureus), a Gram-positive pathogen, is considered a serious threat
by the CDC due to the emergence of resistant populations and its propensity to form biofilms, limiting the
antibiotics that can be used for treatment. Patient populations with compromised immune systems, such as
those here at St. Jude Children’s Research Hospital, are at a high risk of developing biofilm infections through
implanted devices that are administering lifesaving care. A class of natural products, the acyldepsipeptides
(ADEPs) have activity against biofilm infections due to their ability to activate caseinolytic protease subunit P
(ClpP), a non-essential conserved protease in Gram-positive bacteria. ADEP binding displaces the ATP-
regulated chaperone protein, leading to uncontrolled proteolysis and cell death. Previous work in our lab has
generated a ureadepsipeptide (UDEP), which improves the stability, selectivity, and potency of the original
ADEP. However, the high mutation frequency of ClpP limits its use as an antibiotic target. When co-dosing
ClpP activators with rifampin, there is a drastic reduction in the emergence of resistance and an additive
decrease in bacterial burden in vivo. To better control tissue distribution, our lab conjugated the lead UDEP
compound to rifampin to generate a hybrid compound called chimerabactin. Chimerabactin has dual-target
engagement and decreased resistance rates in S. aureus, but the molecule requires a complicated synthesis
route with a minimum of 21 steps and is over 25 Å in size, so there is an imminent need for structural
modifications. I propose an approach in which we improve on a small molecule ClpP activator series
and establish the feasibility of using this series instead of the UDEP compound. I will use
computational modeling and QSAR studies to inform chemical design before synthesis and validation
using previously established workflows in the lab.

Public health relevance
Project Narrative S. aureus is a public health threat due to the emergence of multi-drug resistance and biofilm formation limiting the available classes of antibiotics that can be used for treatment. Dual-targeting of the caseinolytic protease subunit P (ClpP) and RNA-polymerase machinery for the development of hybrid antimicrobials will introduce a unique target, active against persister cell populations, and with a low frequency of resistance. I propose a workflow to improve our lab’s current compound utilizing computational methods to drastically reduce the lead optimization time and expense.